CSRD Research Career Scientist Award Application

Dr. Amy Byers’ research is predominately focused on suicide prevention in older Veterans. This work is
highly relevant to and has very high impact on Veterans and VA healthcare. Veterans 50 years and older have
the highest number of lives lost to suicide and make up the majority (> 70%) of the Veteran population. Older
adults and, in particular, older Veterans accumulate a significant amount of life experiences, including suffering
multiple comorbidities, losses, and traumas, that impact their mental and physical well-being. Even further
adding to the complexity, mental health care often occurs in non-mental health settings under the influence of
personal and society notions and stigmas about mental illness and about aging. Dr. Byers’ Lab is uniquely
positioned to conduct research at this level of complexity. Dr. Byers has developed a deep, clinically relevant
understanding of the nature of mental health in late life, its course, treatment and impact. Her research covers
multiple sub-areas of late-life mental health, i.e., late-life suicide, late-life posttraumatic stress disorder, mental
health services use with age, geriatric depression, and gerontological biostatistics. In particular, understanding
suicide-related outcomes in older adults/Veterans requires substantially different conceptual and methodologic
considerations, which Dr. Byers and her team are uniquely qualified to undertake. There are 4 over-arching
research areas and Aims that Dr. Byers will actively pursue during the proposed Research Career Scientist
Award period: 1) To characterize and identify patterns of health services use and diagnostic profiles at a
national level among older adults/Veterans who have experienced late-life suicide or mental health disorders;
2) To identify predictors of late-life suicide; 3) To advance late-life suicide and mental health research in
prominent health disparity and vulnerable groups; and 4) To advance suicide and neuropsychiatric research in
Veterans incarcerated and returning to community in later life. In summary, the first 3 Aims are supported by
an on-going VA CSR&D Merit Award (I01 CX001119; PI: Byers). Aim 2 and 3 are further supported by a
Genius Award (PI: Byes) from the UCSF Older Americans Independence Center (NIA-funded Pepper Center).
Aim 4 is supported by a NIMH Multi-PI R01 grant in collaboration with Dr. Lisa Barry from University of
Connecticut (MH117604; Multi-PI: Byers/Barry). Additionally, Dr. Byers and Dr. Barry were recently awarded a
NIMH/NIA Supplement to the parent grant to determine the burden of Alzheimer’s disease and related
diseases in older adults/Veterans with a recent history of incarceration. There are many seminal contributions
by Dr. Byers’ Lab in terms of highly cited papers in high impact journals in support of these on-going activities.
To name a few, she was the first to determine the high occurrence of late-life mood and anxiety disorders at a
national level, first to determine and characterize nationally that the majority (~70%) of older adults with mood
or anxiety disorders did not use mental health services, first to identify comorbidity profiles in Veterans 65
years and older who were last seen in primary care prior to a suicide attempt, first to determine in a national
cohort that risk of suicide attempt was increased in Veterans recently diagnosed with mild cognitive impairment
or dementia (in press at JAMA Psychiatry), first to provide evidence that hormone therapy is an indicator of
suicide risk among midlife to older women Veterans (even independent of psychoactive drugs), and seminal
work showing a nearly 5-fold greater risk of a subsequent suicide attempt in older Veterans transitioning from
prison to community. Dr. Byers is investigating other unique patterns of potential markers and predictors of
late-life suicide risk (supported by I01 CX001119), including “high-risk” medication use (i.e., benzodiazepines,
sedative-hypnotics, opioids, antidepressants, antiepileptics, and antipsychotics) and polypharmacy patterns,
and conducting seminal research to determine specific medications causally linked to risk of suicide in older
Veterans. Moreover, she is actively pursuing more research on vulnerable groups (female, minority, homeless,
and PTSD), including Veterans transitioning from incarceration to community in later life.

Public health relevance
Suicide prevention is VA’s highest clinical priority, and the greatest number of lives lost to suicide are in older Veterans. However, most national suicide prevention programs target younger military personnel and Veterans returning from combat. Thus, the on-going work by Dr. Amy Byers on suicide-risk detection and prevention in older Veterans is imperative. She is a leader in investigating salient risk factors related to late-life suicide using nationally based, large-scale data. Her work uses substantial creativity and originality to identify new and timely issues on which to conduct research projects and to extend existing knowledge in the areas of suicide, aging, and mental health. She has an active and vigorous research program that is capable of obtaining continued VA Merit Review funding, as well as extramural peer review funding. The Research Career Scientist Award will support Dr. Byers’ on-going research activities in these areas, advancing the current landscape of VA’s suicide prevention programs.